Pathogenesis of lung injury mediated by lung-restricted antibodies

Primary graft dysfunction (PGD) affects over 50% of recipients within the first 24-72 hours after lung
transplantation. PGD is the dominant risk for post-lung transplant mortality, transplant-associated multi-organ
dysfunction, and chronic lung allograft rejection. Since lung transplantation is increasingly utilized as a life-saving
treatment for both chronic lung diseases as well as acute respiratory distress syndrome, mitigation of PGD
represents a critical component of a multi-pronged strategy to improve transplant outcomes.
In a prospective clinical study, we found that over 30% of patients undergoing lung transplantation have lung-
restricted autoantibodies (LRA) against self-antigens, collagen type V and k-alpha 1 tubulin, which was strongly
associated with the development of PGD. Pre-existing LRA is associated with complement activation, neutrophil
recruitment, a lower PaO2/FIO2 and worsened lung injury, all clinical hallmarks of PGD. In parallel work, we
identified an important role for donor derived non-classical monocytes (NCM) that are retained in the lung grafts
after perfusion in the development of PGD. Donor derived NCM sense damage associated molecular patterns
(DAMPs) via redundant signaling through TLR2/4 to release CXCL2 and other cytokines that directly recruit
neutrophils to the allograft and activate donor alveolar macrophages to recruit recipient classical monocytes
stored in the spleen. Upon migration to the lung graft, the recipient classical monocytes (CM) permeabilize the
pulmonary endothelium and amplify the extravasation of neutrophils to the alveolar space. Our published and
preliminary data suggest important interactions between LRA, donor derived NCM and recipient derived CM in
determining the severity of lung injury after lung transplantation. Specifically, we found that LRA bind Fc
receptors on donor derived NCM to promote their retention in the allograft and activation. This enhances the
recruitment of CM to the allograft which release IL-1. Permeabilization of the endothelium in response to IL-1
allows LRA access to the lung interstitium and promotes neutrophil migration into the alveolar space. In addition,
CM release matrix metalloproteinase-8 (MMP8), which cleaves extracellular matrix proteins to release
sequestered self-antigens and expose their immunogenic epitopes, enabling the extravasated LRA to form
immune complexes. The resulting immune complexes activate complement to exacerbate lung injury in the first
24 hours after lung transplantation. Further preliminary data suggest LRA immune complexes activate donor
derived NCM to release CXCL2 and promote neutrophil recruitment via a pathway that requires Src, PI3K and
BTK but is independent of the TLR2/4/MyD88 pathway activated by DAMPs, resulting in delayed lung injury in
the 48 to 72 hours after transplant. We will test the hypothesis that LRA interact with donor derived NCM and
recipient CM to worsen PGD via complement dependent and independent pathways. Aim 1. To determine the
mechanisms through which LRA activate NCM. Aim 2. To determine the role of IL-1 and MMP-8 released
from recipient CM in the cleavage of sequestered self-antigens and their binding to LRA.

Public health relevance
Primary graft dysfunction (PGD) is a deadly complication following lung transplantation affecting over 50% of recipients. While PGD has been traditionally thought to be due to ischemia-reperfusion injury, we have discovered that transplant recipients have high incidence of pre-existing lung autoantibodies which react with the newly transplanted lung causing severe damage which presents as PGD. In the prior funding cycle, we identified novel pathways through which the pre-existing autoantibodies cause damage to the transplanted lung. In the next cycle, we will identify clinically actionable treatments to protect the transplant recipients against the damaging effects of these autoantibodies.